HEU outcomes: population-evaluation and screening strategies (HOPE)

Abstract
Globally, the number of HIV-exposed uninfected (HEU) children/adolescents is growing, with 1.2 million HEU
infants born annually1. There is evidence that HEU children have increased morbidity and mortality, and lower
neurocognitive scores than their HIV-unexposed (HUU) counterparts. The parent HOPE study (NICHD
R33103079) has been designed to compare neurodevelopmental outcomes between HEU and HUU children
from 6-weeks of age to 3 years in a longitudinal cohort and to assess longer term effects in a multi-site cross-
sectional age-stratified cohort. The HOPE study will assess influence of maternal viral load, ART timing, and
regimen on HEU outcomes, and explore whether HEU neurodevelopmental outcomes are associated with
telomere length (TL).
Administrative Supplement: This supplement application falls within the scope of work of the parent
application. The parent grant scope of work included assessment of cofactors that influence HEU/HUU
neurodevelopmental outcomes including psychosocial, telomere length, and infectious diseases. In this
Administrative Supplement proposal, we request funding for:
• Goal 1. To characterize family structures and explore the roles of parental caregiving (including paternal
perspectives) in child neurodevelopmental outcomes in HEU and HUU using participatory visual qualitative
methods. Qualitative data will complement extensive quantitative data from the cohort of 1000 HEU and
1000 HUU in understanding how caregiver structure influences neurodevelopmental outcomes in both
groups of children.
• Goal 2. To conduct maternal telomere assays (parent budget supports infant telomere assays) and use this
data to better characterize cofactors of infant telomere length (TL). Maternal TL assays [already approved
by KNH and UW ethical committees] are a key predictor of infant TL).
• Goal 3. To conduct SARS-CoV2 antibody testing [already approved by UW Human Subjects Division] on
infant dried blood spots [DBS] already collected at 6 weeks and 1, 2, 3 years) to assess impact of maternal
peripartum SARS-COV2 on already measured longitudinal infant neurodevelopmental outcomes.
These goals leverage the unique HOPE cohort and enable more comprehensive assessment of critical
determinants of child neurodevelopment.

Public health relevance
Narrative There is an expanding population of HIV-exposed uninfected children (HEU) globally, and evidence that HEU children have poorer outcomes than HIV unexposed uninfected (HUU) children. We are currently comparing neurocognitive outcomes in HEU and HUU children followed from 6 weeks to 3 years of age in the HOPE study. In this Administrative Supplement proposal, we request additional funding to better understand the influence of family determinants, telomere length, and maternal COVID-19 infection on neurodevelopmental outcomes within the HOPE cohort.